Transition to Cardiac Rehabilitation (T2C) to Address Barriers of Multimorbidity and Frailty

Cardiac rehabilitation (CR) is an evidence-based secondary prevention program for patients with
cardiovascular disease (CVD) that aims to stabilize patients clinically and to restore physical function and
health after a CVD event. It is well-suited to the needs of the aging Veterans Health Administration’s (VHA)
aging population which is prone to CVD in a context of comorbidity, frailty, and associated functional decline.
Unfortunately, few eligible Veterans participate. Logistic challenges are a key barrier as few VHA site-based
CR programs are available. The Promising Practice home-based CR (HBCR) is a VHA initiative that was
designed to improve CR participation using a novel home-based approach. While HBCR has been
demonstrated to be effective for Veterans who attend, only few participate. Many Veterans eligible for HBCR
remain encumbered by comorbidity and frailty, and often lack confidence and/or perceived capacity for home-
based formats of care. The Transition to CR (T2CR) intervention is a 2-phase program that aims to improve
the process of HBCR and to thereby better respond to Veterans’ needs. T2CR Phase 1 is a ~2 day face-to-
face program between the initial CVD hospitalization and home that includes comprehensive assessment of
holistic risks (CVD and non-CVD), functional limitations, and psychosocial circumstances. Individualized
pragmatic plans are formulated to ensure HBCR is feasible, safe, and practical despite aggregate complexity.
Goal setting, adherence reinforcements, and education are integrated; exercise practice is emphasized; and
consultations for comorbid issues and telemedicine video facilitation are arranged. T2CR Phase 2 is HBCR
that is enriched by the orientation, practice, consultations, supports, and goal setting that were initiated in
T2CR Phase 1, as well as innovative exercise training techniques for patients who are frail and/or functionally
impaired. T2CR is aligned with the already existing Coordinated Transitional Care (C-TraC) Program. C-TraC
nurse practitioners currently hone medication management, medical follow-up, and education as hospitalized
Veterans transition to home, but do little to guide recovery of physical function. By facilitating referral to the
T2CR intervention, C-TraC care will be enhanced. Using a hybrid efficacy-implementation (type 1) design, we
propose a randomized controlled trial to study T2CR versus usual HBCR in the VA Pittsburgh and Boston
Healthcare Systems. Quantitative endpoints will include functional gains (assessed using the Activity Measure
for Post-Acute Care [AM-PAC CAT]) over 365 days as well as a 5-Times Sit-To-Stand performance measure.
The number of CR sessions attended, rehospitalizations, and Healthy Days at Home will be assessed.
Patients’ perceptions of feasibility and acceptability of T2CR will be also be evaluated. Providers’ perceptions
of will be evaluated as well; the Consolidated Framework for Implementation Research (CFIR) framework will
be used to structure their insights. Patient and provider feedback will be applied to refine implementation
strategies with the goal to ultimately extend T2CR throughout the entire ORH Promising Practices network.

Public health relevance
Cardiac rehabilitation (CR) is a secondary prevention program for patients with cardiovascular disease (CVD). It is especially valuable as CVD increasingly occurs in combination with comorbidity, frailty, and complexities of care that predispose patients to functional decline, disability, and high costs. Still, few Veterans participate in CR, in part because of the difficult logistics to attend. Promising Practice home-based CR (HBCR) was developed to increase CR participation, but many Veterans remain too limited by comorbidity and frailty for participation. A Transition to CR (T2CR) intervention is a face-to-face program that fosters vital skills, education, insights, motivation, and patient-provider relationships conducive to successful HBCR thereafter. This study compares Veterans eligible for CR who are randomized to T2CR intervention versus usual care. Differences in functional capacity, HBCR participation, and healthy days at home are compared over one year. Patients' experiences and providers' perspectives of barriers and facilitators to T2CR are also compared.